Integration Of Macromolecular Synthesis

We continue to study a large number of both general and specific effects of ppGpp that relate to the integration of molecular regulation of bacterial physiology and gene expression. We have four reviews this year of these topics. One of the major surprises of our ongoing work is repeatedly finding that the common views of specificity of transcription factor functions are somewhat blurred. For example, the GreA transcription factor that classically affects elongation has been described in our earlier reports to also alter open complex formation during initiation of ribosomal promoters that are inhibited by ppGpp. In special genetic backgrounds, GreA overproduction can also reverse requirements for several amino acids (ILVSTFDQH) biosynthetic phenotypes occasioned by a ppGpp-deficiency. This year (Nucleic Acids Research reference), we report that greA transcripts are unusual because of the existence of a special terminator between two tandem greA promoters and the greA ORF. Because of this terminator, about 2/3ds of the total transcripts terminate imprecisely over a 10 nt range. The two promoters generate two small RNA chain populations with lengths of 40-50 nt and 50-60nt. This is the first discovery of this degree of imprecise termination for E. coli for an "intrinsic" terminator, (one that functions without additional factors). The possibility that these small RNA populations have regulatory functions is underscored by fitness assays, by evolutionary conservation and by transcriptional profiling. This year we also report our re-evaluation of the role of ppGpp as a determinant of enteric bacteria cellular content of DNA, RNA and protein as a function of growth rate (Environmental Microbiology reference). It has been known for over 50 years that the cellular content of these macromolecules was controlled solely by the exponential growth rate and not the composition of the growth media needed to achieve a given growth rate. This regulatory phenomenon is called growth rate control. Since our discovery over 40 years ago of ppGpp and that ppGpp could negatively regulate rRNA synthesis during the stress of amino acid starvation, it has been uncertain whether ppGpp causes growth rate control at all, in part, or fully. During nearly the past two decades the controversy has been limited to the question of whether or not multiple redundant regulatory systems exist in addition to ppGpp. These past discordant results have arisen in other laboratories using strains we constructed to be completely deficient in ppGpp. Using similar strains, our re-evaluation differs from earlier experiments through the use of especially sensitive assay techniques (fluorescent dyes), development of nutritionally defined media for growing ppGpp-deficient cells for the first time and deriving special culture conditions to avoid suppressor mutations in RNA polymerase that otherwise confound results. We believe our findings apparently finally resolve this seemingly intractable controversy. Our conclusion also greatly simplifies the explanation for growth rate control in E. coli because ppGpp is found to be the major source of growth rate control.